Acquisition of a FACSymphony S6 Sorter for the University of Toledo Flow Cytometry Core

This is a shared instrumentation grant application to acquire a BD FACSymphony S6 flow
cytometer to replace a 16-year-old BD FACS Aria™ IIu for the University of Toledo
(UToledo) Flow Cytometry Core (FCC). The FCC services both the UToledo Health
Science and Main Campus research communities. Our BD FACSAria™ IIu is the only cell
sorter available at UToledo for research and graduate student research training. The
FACSAria™ IIu is three generations removed from current flow-based technology. The
benefit of replacing the current end-of-life flow cytometer in the UToledo FCC is multifold.
First, replacing the existing cell sorter will allow current and new users with NIH funding
to continue to access this important technology for their experimental design. Failure to
replace the current instrument in the near future will result in the loss of this extremely
valuable tool for experimental applications in molecular biology, pathology, virology,
immunology and cell biology due to end-of-life notice from the manufacturer. Second,
replacing the current instrumentation with a new state of the art flow sorter will enhance
the ongoing research of our established core. Our users will have access to experts in
flow cytometry who will facilitate consultation, training and analysis with long-term benefits
for sustaining the research enterprise with cutting edge instrumentation and a track record
of long-term institutional support including a greater than $129,000 cost share. Faculty,
staff and students will be able to move forward with innovative experiments with ease and
efficiency due to the expertise that the established core facility provides to the UToledo
research community. Lastly, state of the art instrumentation plays an integral role in the
intellectual environment, recruitment and retention of talented faculty, staff and students.
We continue to advance the research activity within UToledo’s COMLS and have recently
been recognized as a nationally ranked medical school for research, have received
funding of a new T-32 G-RISE award to support training of students underrepresented in
translational and biomedical research. This new instrument represents a unique resource
that is in high demand within our research community. This instrument will help to
advance the scientific goals of nine major NIH-sponsored projects and promote the
development of new projects by existing minor and new users. Importantly, this fits well
in our overall strategy to improve the significance and impact of our research within the
college and for the benefit of our nation and world.

Public health relevance
Project Narrative This is a shared instrumentation grant application to acquire a BD FACSymphony S6 flow cytometer to replace a 16-year-old BD FACS Aria™ IIu for the University of Toledo Flow Cytometry Core. The BD FACSAria™ IIu is the only cell sorter available and services both the UToledo Health Science and Main Campus research communities and is on end- of-life service and support. Acquisition of a new state of the art flow cytometer will be operated as a shared resource to accelerate the health-related research of nine major users who are engaged in NIH-sponsored projects focused on virology, cancer, hypertension, transplantation, immune response to infection and arthritis.